Gastric Cancer Prevention: Evaluating U.S. Risk Factor Trends and New Technology

DESCRIPTION (provided by applicant): The goal of the proposed research is to identify effective gastric cancer prevention programs that improve cancer outcomes, reduce disparities, and enhance the cost-effectiveness of gastric cancer prevention in the U.S. This will be accomplished by constructing a flexible decision-analytic simulation model of gastric cancer capable of estimating the contribution of risk factor patterns on gastric cancer trends and assessing the costs, benefits, and cost-effectiveness of primary (smoking cessation) and secondary (surveillance) prevention strategies. As several factors are changing the landscape of gastric cancer control, including a better understanding of the disease natural history, role of risk factors on disease progression, and new noninvasive endoscopic technology to detect and treat precancerous and cancerous lesions, this model will synthesize available clinical, epidemiologic, and economic data to project long-term outcomes and guide clinical study design. Our specific aims are: (1) to develop a natural history model of gastric cancer, including the role of risk factors on disease progression. This model will be empirically calibrated using U.S. epidemiologic data on age-specific prevalence and incidence of precancerous lesions and cancer; (2) to estimate the decline in gastric cancer incidence attributable to declining prevalence of H. pylori, smoking, and other risk factors. Using a population-based model of gastric cancer we will incorporate data on risk factor trends to forecast gastric cancer incidence and mortality; (3) to assess the cost-effectiveness of technology-based surveillance and treatment strategies for patients with precancerous lesions. We will evaluate the effectiveness of endoscopic and serology-based diagnostic and therapeutic technologies for dysplastic and asymptomatic cancerous lesions; (4) to compare the relative effectiveness of alternative gastric cancer control strategies on disparities. We will develop natural history models for specific race/ethnicity, immigrant, and other select subgroups, incorporate demographic trends, and assess the impact of prevention and treatment strategies to improve cancer outcomes and reduce disparities. In summary, this research will synthesize the best available data, improve upon an existing modeling framework, and develop a new set of analytic tools to estimate and project gastric cancer trends; establish management guidelines for patients with gastric precancerous lesions; and provide insight on the relative costs, benefits, and risks associated with different gastric cancer prevention and control strategies. My career goal is to become an independent investigator dedicated to the application of multidisciplinary, decision- analytic methods to improve cancer prevention and control policies. In conjunction with additional training in secondary data analysis, advanced decision-analytic methods, and epidemiology, the execution of this proposed mentored research in a multidisciplinary and highly-collaborative environment will provide the additional experience, knowledge, and skills needed to successfully transition to research independence.

Public health relevance
PROJECT NARRATIVE This project evaluates gastric cancer prevention strategies in the U.S., including targeted risk factor interventions and new endoscopic techniques for early detection and treatment of precancerous lesions. The objective is to improve cancer outcomes, reduce disparities, and enhance the cost-effectiveness of gastric cancer prevention in the U.S. __SpecificAimsTextDelimiter__ RESEARCH PLAN 10. Specific Aims The goal of the proposed research is to identify effective interventions for gastric cancer control by developing and analyzing a Gastric Cancer Policy Model. Gastric cancer is the second leading cause of cancer-related deaths worldwide, and eleventh in the U.S. (17, 18). Based on current age-specific rates of gastric cancer and projected demographic changes, the annual number of expected deaths worldwide will increase from 700,000 to 1.4 million by 2030 (17). While the absolute number of U.S. cases has fallen, more than 10,000 Americans die each year from gastric cancer, and disparities by race and ethnicity persist. We propose to develop a flexible decision-analytic simulation model of noncardia intestinal type gastric adenocarcinoma capable of analyzing the economic and population impacts of cancer control interventions. We will integrate data from cross-sectional surveys, cohort studies, and cancer databases to develop and validate the disease simulation model. We will specifically use the National Health and Nutrition Examination Surveys (NHANES) and similar survey databases to estimate Helicobacter pylori prevalence, smoking rates, and other risk factors and the Surveillance, Epidemiology and End Results (SEER) program for cancer data. We will then use the model to i) estimate the contribution of risk factor trends on past and future gastric cancer incidence, ii) evaluate the clinical benefits and cost-effectiveness of biomarkers to detect high-risk individuals for endoscopic surveillance to prevent gastric cancer, and iii) assess the impact of alternative control strategies on cancer disparities by race and ethnicity, nativity/immigrant status, and other subgroups. We hypothesize that risk factor-focused and technology-based interventions will enhance gastric cancer prevention efforts by improving life expectancy and reducing disparities. Employing a decision-analytic approach, we will use mathematical modeling and rigorous data analysis to examine this hypothesis, and thereby identify effective interventions, describe the tradeoffs and ethical considerations associated with different approaches, and ultimately inform important clinical and policy questions surrounding gastric cancer prevention. The proposed research will carry out the following Specific Aims: Aim 1: Develop a gastric cancer natural history model for the U.S. 1.1 Construct a U.S. Monte Carlo model 1.2 Calibrate the model based on data from SEER and other clinical databases 1.3 Conduct internal and external validation exercises to compare the model output to published epidemiologic and cancer mortality data not used to parameterize the model Aim 2: Estimate contributions of risk factors on the decline in gastric cancer incidence in the U.S. 2.1 Refine model to function as a population-based model capable of reflecting risk factor trends 2.2 Use the model to determine the contribution of risk factors on the decline in gastric cancer incidence 2.3 Project future incidence of gastric cancer for the U.S. population Hypothesis: Trends in modifiable risk factors explain a significant proportion of the decline of gastric cancer incidence, and will contribute to future decline. Aim 3: Compare the clinical benefits and cost-effectiveness of technology-based prevention strategies 3.1 Add endoscopic and serology-based surveillance strategies to the model 3.2 Use the model to estimate the effectiveness, costs, and cost-effectiveness of various strategies Hypothesis: New diagnostic and therapeutic technologies will vary in effectiveness and cost-effectiveness to improve gastric cancer outcomes and may change existing recommendations for H. pylori screening. Aim 4: Assess the impact of alternative gastric cancer policies on cancer disparities between race/ethnicity, nativity/immigrant, and other subgroups 4.1 Refine gastric cancer natural history model for specific subgroups 4.2 Evaluate the effectiveness of prevention and control strategies to reduce subgroup disparities 4.3 Assess how projected demographic changes will influence trends in disparities over time Hypothesis: Gastric cancer policies will differ in their effectiveness to reduce disparities and the magnitude will vary by disparity summary measure and interpretation of society's underlying ethical values. By synthesizing clinical, epidemiologic and economic data, and applying the methodology of decision science to critical policy questions, this proposed research will identify interventions that effectively improve cancer outcomes, reduce disparities and enhance the cost-effectiveness of gastric cancer prevention in the U.S.